2024 DNA Damage, Mutation and Cancer Gordon Research Conference and Seminar

SUMMARY. The DNA Damage, Mutation and Cancer Gordon Research Conference (GRC) is a leading
international scientific conference focused on advancing science through the presentation of cutting-edge and
unpublished research, prioritizing time for detailed discussion after each talk, and fostering informal interactions
among scientists of all career stages. The conference is five days long and held in an accessible location
(Ventura, CA, which is a shuttle ride from Los Angeles International Airport). The location is adjacent to a beach,
which lends itself to leisure activities to foster informal interactions that are important to forge scientific
communities. Afternoon free time and communal meals also support such interactions, and two of the dinners
will have “Theme Tables,” which involves trainees having the opportunity to sign up for specific tables that have
been assigned to speakers and other notable attendees (e.g., senior scientists in industry and scientific editors).
The program includes a diverse set of invited speakers, with several additional slots for short talks to be selected
from submitted abstracts by a selection committee. In addition to speaking presentation sessions, the conference
has substantial designated time for poster sessions from individuals of all career stages. The conference will be
all-inclusive and emphasize trainee participation beyond the associated Gordon Research Seminar (GRS) pre-
meeting for trainees that will precede the GRC. There will be a “Power Hour” session for attendees from all
career stages for a guided discussion of support and growth of women in science, support for all
underrepresented population scientists, and aspects of work/life balance. Finally, as another mentoring
component, we will request that all session chairs prioritize questions from trainees and junior faculty during the
discussion sessions. The scientific focus of the program is research on defining basic mechanisms of the DNA
damage response (DDR) and leveraging this information for translational research on cancer biomarkers and
therapeutics. The DDR is central to cancer biology. In addition to the importance of mutagenesis in the etiology
of cancer, many treatment modalities involve the DDR, e.g., clastogenic chemotherapeutics, radiotherapy, and
synthetic lethality via PARP inhibitors and other emerging targets like DNA polymerase theta. Accordingly, the
program covers the range from structural biology of key players in the DDR, mechanisms of mutagenesis and
chromosomal rearrangements in cancer, DDR and DNA replication mechanisms as relates to mechanisms of
therapeutics, and mutations and deregulation of the DDR and cancer. In addition, since the importance of the
DDR in cancer is related to its interplay with the immune system, there is a session on this topic. Finally, there
is a session on the DDR in the brain, which is important for understand both neurodegeneration as well as
malignancies and metastasis to the brain. The sessions will include new approaches and technologies, and
provide attendees a grasp of the current landscape of research on the mechanisms of the DDR through
application of this knowledge to improve cancer treatment outcomes.

Public health relevance
NARRATIVE. Several cancer treatment modalities involve the DNA damage response, and furthermore mutations and chromosomal rearrangements are hallmarks of cancer. The 2024 Gordon Research Conference on DNA Damage, Mutation and Cancer will focus on cutting-edge research on defining basic mechanisms of the DNA damage response and leveraging this information for translational research on cancer biomarkers and therapeutics. Thus, this conference will support the mission of the NIH to improve cancer treatments and patient outcomes.